Physical, molecular, and cellular control of wound closure

Abstract
The skin protects animals and humans from harm. To this end, the skin needs to detect and
repair wounds. Slowed or failed wound detection and repair causes different skin disorders and
signaling pathways that detect and repair wounds are potential targets for clinically important
therapeutics. The goal of this project is to identify the pathways and mechanisms that the skin
uses to detect and repair wounds. For this, we combine genetics and imaging in zebrafish
embryos with computational modeling. Identical to the human embryonic skin, the zebrafish
embryonic skin consists of two cell layers – an outer and a basal layer. Due to its transparency,
the zebrafish embryonic skin can be imaged at high resolution, which permits quantitative
measurements and data-based computational modeling. We have found a G-protein coupled
receptor (GPCR) signaling pathway that is activated in the skin cells at the margin of wounds,
and we have built tools to image the force-generating and force-transmitting machinery in skin
cells. Using these tools, we will address three questions. First, we will decipher how the skin
cells use the GPCR signaling to detect wounds. Second, we will ask how the two layers of the
skin cooperate to move and close wounds. Third, we will use the quantitative imaging data and
measurements of physical properties of the skin to generate a physical model of a two-layered
skin that we will test and refine using physical and genetically perturbations. Since epithelial
integrity is essential for many organs including the lining of the gut, blood vessels and lungs, the
proposed studies will provide necessary context to better understand epithelial barrier function
in general and should inform us about strategies of how to correct epithelial disorders.

Public health relevance
PROJECT NARRATIVE To protect humans from harm, the skin needs to rapidly seal wounds. Using the embryonic skin in zebrafish as a model, we are asking how the skin detects a wound and how the different skin layers work together to seal a wound. This will offer a basis to address medical problems such as skin abnormalities and slowed wound healing.